Acquisition of an Olympus SZX7 fluorescent stereo microscope for dissecting late-stage Drosophila embryos and selecting Drosophila embryos with GFP/RFP tagged genes

Acquisition of an Olympus SZX7 fluorescent stereo microscope for dissecting late-stage
Drosophila embryos and selecting Drosophila embryos with GFP/RFP tagged genes
This proposal is for the acquisition of an Olympus SZX7 fluorescent stereo microscope to
replace an old and broken fluorescence stereo microscope, which was used to select GFP-
positive fly embryos and dissect fly embryos when ring light is provided. The awarded NIH R15
research project is to study the role of a poorly understood Osiris (Osi) gene family in regulating
tube maturation in Drosophila trachea, which is a premier system to reveal fundamental
mechanisms of tubular organ formation.
The Drosophila trachea is a ramifying network of epithelial tubes with a monolayer of epithelial
cells surrounding an apical lumen. During tube maturation, the apical secretion burst deposits
large amounts of luminal matrix components to the apical lumen. Then, this lumen is cleared
before air fills the lumen. The goal of the awarded project is to reveal the functions of Osi proteins
as “broader coordinators” of protein trafficking during tube maturation. To test this hypothesis, we
will complete the following three specific aims: Aim. 1 Determine the function of Osi genes in the
trafficking of the apical luminal matrix during tube maturation. Aim. 2: Determine the function of
Osi genes as coordinators to control endosome-mediated protein trafficking. Aim. 3: Identify
proteins that directly bind to Osi proteins. To carry out the proposed experiments, we will analyze
protein trafficking and structural changes in late-stage embryos by immunostaining. In addition,
we will analyze the dynamic coordination of vesicular trafficking in vivo by observing GFP-tagged
vesicle markers and RFP-tagged protein markers simultaneously in Osi mutant background.
The tracheal phenotypes in Osi mutants appear in late-stage embryos (mid-stage 17). Due to
cuticle formation, antibodies cannot enter embryos effectively without dissection. Therefore, we
need to dissect the late-stage embryos before immunostaining. In addition, we will generate fly
strains that carry GFP-tagged vesicle markers and RFP-tagged luminal protein markers in Osi
mutant background. Since some marker genes are located on the same chromosome as Osi
genes, we will recombine these marker genes to Osi mutant background genetically. Therefore
the potential live recombinant fly embryos that carry GFP- or RFP- tagged marker genes can be
selected using a stereo fluorescent microscope. Unfortunately, our old fluorescence stereo
microscope that can be used to dissect late-stage fly embryos as well as to select live embryos
that carry fluorescently tagged genes is broken beyond repair. Thus, this requested Olympus
SZX7 fluorescent stereo microscope will allow us to carry out the proposed experiments (Aim.
1 and Aim. 2) on time. Without it, our progress on the project will be significantly delayed.

Public health relevance
Tubes are fundamental building blocks in human organs or organ systems, including lungs, kidneys, and vasculature. Defects in how these tubular organs develop and take shape, and how tube sizes are regulated, can cause critical problems (and even death) for developing organisms, including humans. As most tubular systems, such as the Drosophila trachea and mammalian tubular organs, are structurally similar, the findings from this study will help us better understand the mechanisms of tubular morphogenesis in vertebrates, and could potentially lead to new avenues for treatments for diseases caused by defects in tubular morphogenesis.